Expanding access to Genomics Methods through Modern Focused Ultrasonication

SUMMARY
The MIT BioMicro Center serves as a centralized resource for MIT researchers to access
genomic and bioinformatics resources as well as expertise in related methodologies. As an
integrated resource, the BioMicro Center is able to support researchers over the entire timeline
of their experiment with assistance available in experimental design, sample extraction and
preparation, sequencing, analysis, and deposition and data management. The facility supports
over 120 laboratories each year and approximately $4.2m of funds in total research
expenditure. The large diversity of research projects supported by the BioMicro Center creates
unique challenges for the shared resource. While many genomics shared resources specialize
in specific assays or focus on a small number of species, no specific methodology represents a
disproportionate fraction of the work supported by the center. Improvements in sequencing
capacity and the success of the BioMicro Center in developing novel protocols to prepare
nucleic acids for sequencing has exposed a number of critical barriers that are limiting
researchers at MIT, preventing them from taking full advantage of new methods as well as
constraining other areas of biological and biomedical research. Foremost among these is a lack
of high-throughput processing of biological samples for extraction and purification of nucleic
acids. Equipment requested in this proposal, a Covaris R230 Focused Ultrasonicator, will
modernize the Center’s ability to isolate biomolecules from a broad spectrum of biological
sources, and to prepare those molecules for genomic, transcriptomic, and epigenomic analysis
using state-of-the-art sequencing technologies. The new equipment will do so by impacting the
workflows in the BioMicro Center in three ways. First, it will enable high-throughput RNAseq of
degraded samples. Second, it will enhance high-throughput preparation of diverse samples
including FFPE tissue. Third, novel plastics used in the instrument will improve epigenetic assay
access and performance. The Covaris R230 will complement the existing portfolio of
instrumentation within the BioMicro Center, leveraging that equipment to enable faculty across
several research centers at MIT to routinely ask highly powered questions to address
challenging biological and biomedical problems. Access to high-throughput and updated
sonication will expand and enhance the capabilities of the Center to support existing research
projects, improving their rigor and reproducibility, while enabling future projects to leverage the
instrumentation to ask broader questions due to the ability to easily handle a larger spectrum of
biospecimens.

Public health relevance
Narrative The explosive improvements in sequencing technologies have enabled researchers to do more complex and more rigorous experiments to address fundamental questions about human development and disease. This new potential has created bottlenecks in processing research samples, limiting researchers’ ability to fully capitalize on the improvements in genomic technologies. This proposal will purchase instrumentation to enable researchers at MIT exploit these new capabilities fully by performing high-throughput extraction and purification of RNA and DNA as well as improve other steps in sample processing.